Using eHealth to Expand Access to Cognitive Behavioral Therapy for Insomnia in Hispanic Primary Care Patients

Over 30 million US adults and nearly 20% of primary care patients suffer from chronic insomnia. Chronic
insomnia is associated with increased morbidity, mortality, and high economic costs, and thus represents a
major public health problem. Importantly, the prevalence of insomnia is significantly higher in Hispanics
(26.5%) than non-Hispanic Whites (22.5%), and this disparity is widening over time. Cognitive behavioral
therapy for insomnia is a robustly effective psychological intervention for treatment of insomnia with sustained
benefits, and is recommended over medications as the first-line treatment for chronic insomnia. Unfortunately,
few receive this standard of care. Hispanics, and particularly those with limited English Proficiency, are even
less likely than non-Hispanic Whites to have access to high quality evidence-based behavioral health care
such as CBT-I, primarily because of the lack of available qualified bilingual behavioral providers trained to
deliver CBT-I in Spanish and costs. Given the increasing prevalence of insomnia among Hispanics, and the
linguistic realities of today's behavioral healthcare work force, the demand for bilingual behavioral health
providers equipped to deliver CBT-I in Spanish significantly outweighs the supply. Advances in health
information technology such as self-guided ehealth treatments represent an innovative and scalable means to
address the supply and demand imbalance that perpetuate mental health care disparities, however its
implementation in underserved communities remains elusive. In fact, CBT-I delivered via an online web-based
platform is as effective as CBT-I delivered in-person, but extant ehealth programs of CBT-I have not been
adapted for use among underserved patient populations. Further, data on the barriers and facilitators of
implementation of these ehealth behavioral treatments in underserved racial/ethnic minority populations were
rarely collected or used to support its integration in primary care. The proposed study will use a hybrid trial
type 1 effectiveness-implementation study design and a mixed methods approach that leverages recent
technological advances in ehealth platforms to (1) enroll 200 Spanish-speaking Hispanic primary care patients
with chronic insomnia into an RCT that compares the effectiveness of a culturally adapted ehealth version of
CBT-I with enhanced usual care on reduction of insomnia symptoms; (2) concurrently assess the
organizational, patient, and provider barriers to implementation, and (3), determine the cost-effectiveness of
the intervention. By leveraging recent advances in e-health and capitalizing on the increasing rates of Internet
use among Hispanic US adults, this study has the potential to expand access to evidence-based alternatives to
pharmacotherapy for the management of chronic insomnia, and to narrow existing racial/ethnic disparities in
access to high quality behavioral health care for primary care patients.

Public health relevance
Chronic insomnia is associated with significant public health burden and most adults seek care for insomnia in the primary care setting. While Hispanics are at greater risk for insomnia than Whites, access to the recommend first-line of treatment, cognitive behavioral therapy for insomnia, is limited especially for Spanish- speakers. We aim to: (a) compare the effectiveness of a culturally adapted ehealth program of cognitive behavioral therapy for insomnia vs. enhanced usual care for Spanish-speaking, Hispanic patients, (b) examine barriers and facilitators to implementation, and (c) determine the cost effectiveness of the intervention.